Role of the L1 retrotransposon in interferon-positive SLE

Project Summary/Abstract
The overall goal of our research is to elucidate the proximal molecular drivers and mechanisms
of systemic lupus erythematosus (SLE) to enable the development of new and better therapies
that target these processes but spare the broader immune system. This proposal will explore the
role of the Long Interspersed Nuclear Element-1 (LINE-1, or L1) in type I interferon (IFN)-positive
SLE. We have discovered that most SLE patients have high-titer autoantibodies against the first
protein encoded by L1, ORF1p and that the titers of these autoantibodies correlate with disease
activity as measured by SLEDAI score, complement consumption, presence of nephritis, anti-
dsDNA and other autoantibodies, as well as with type I interferon gene induction.
Our working hypothesis is that the biology of L1 is intimately connected with the pathogenesis of
SLE by two mechanisms: i) driving autoimmunity to the virus-like L1 protein complexes that
contain RNA and DNA; and ii) generating aberrant DNA by reverse-transcribing RNAs (including
its own) and triggering DNA-sensor signaling to induce type I IFNs.
AIM 1. To characterize the expression of L1 in SLE. The cell types that express the highest
levels of L1 in SLE are the neutrophil and the low-density granulocyte. The L1-expressing
neutrophils show signs of activation, and biomarkers of neutrophil NETosis are elevated in patient
serum. By RNA-Seq we have identified one dominant (chr4q22.1) and six additional distinct
human-specific L1 elements as the origins of the elevated transcripts and ORF1p protein. We will
solidify these observations, detect and analyze their dependence on patient gender and disease
parameters. We will examine factors that influence the transcription of these loci, and we will ask
if stress granules containing ORF1p are released from neutrophils undergoing NETosis or other
forms of cell death. These experiments will be complemented by asking if other proteins present
in stress granules are also autoantigens in SLE.
AIM 2. To elucidate the role of L1 ORF2p in type I IFN induction in SLE. Several recent
papers in top journals have demonstrated a connection between L1 expression and the induction
of IFN in cellular senescence, Crohn's disease, and in cancer cells. To determine how these
findings apply to SLE, we will analyze L1-expressing neutrophils for activated DNA sensors, the
signaling pathways from these sensors, and the type I IFN themselves. We will use an
ultrasensitive method to quantitate ORF2p and then use inhibitors of the its RT activity to
determine if it drives type I IFN production. Lastly, we will ask if silencing the DNA sensor
DAI/ZBP1 blocks this IFN production.

Public health relevance
Project Narrative This new projects will explore the role of the Long Interspersed Nuclear Element-1 (LINE-1, or L1) in type I interferon-mediated SLE. We will continue to characterize autoantibodies against L1-encoded proteins, ask how early in the disease they appear, how L1 transcription is upregulated in SLE, which cells that express it, and if the L1 expressing cells also contain reverse-transcribed RNA and interferon beta. Finally, we will test inhibitors of L1 reverse transcriptase in these cells.